Identifying and Measuring Domains of Structural Ableism to Advance Health for the Disability Community

Structural ableism, defined as the processes, policies, and institutions that privilege able-bodied people over disabled people, is a root cause of health disparities faced by the disability community. A necessary first step to addressing these disability health disparities is to create validated measures of structural ableism, which is the goal of this five-year project. Aim 1 will characterize the multiple factors that comprise the construct of structural ableism, which will improve our understanding of the multidimensionality of structural ableism in ways that support measure development. This aim synthesizes historical, policy, and qualitative approaches, drawing on extant texts and key informant interviews. Aim 2 develops and validates an individual-level measure of structural ableism. In partnership with the disability community, we will translate our findings from Aim 1 into a comprehensive measure of an individual’s experiences across domains of structural ableism. This measure will facilitate the identification of relationships between structural ableism and health outcomes at an individual level. Aim 3 measures structural ableism at a community level using publicly available datasets and explores its relationships with health outcomes. We will use both participatory and statistical approaches to develop a cross-domain composite measure of structural ableism. This includes partnering with the disability community via community engagement studios to inform this process. The resulting measure will help quantify the relationship between structural ableism and health outcomes at a community level. Across all three aims, we take an interdisciplinary and community-grounded approach, including people with a wide range of disability types and experiences in all steps and phases of this work. Our interdisciplinary team has expertise in disability studies, public health, medicine, health policy, systems engineering, sociology, and cultural anthropology, and is led by two disabled PIs. Most importantly, our approach is deeply community-informed, drawing on multiple community partnerships from local and national organizations, and an advisory committee of disabled activists, advocates, and scholars, as well as researchers with expertise in developing similar measures. By the end of the five-year project, this work will have established the characteristics of structural ableism, developed both an individual- and community-level measure of structural ableism, and used these measures to explore relationships between structural ableism and health outcomes. Moreover, the measures developed during this project will lay the foundation for identifying and evaluating novel interventions aimed at addressing structural ableism, which should be co-created with the disability community.

Public health relevance
Structural ableism drives many of the health disparities faced by disabled people across social determinants of health, healthcare access, healthcare quality, and health outcomes. This project will characterize dimensions of structural ableism, and create measures to assess it which are essential first steps to identifying how structural ableism impacts health outcomes among disabled people. This work will provide measures needed to identify and evaluate novel interventions aimed at addressing structural ableism, which should be co-created with the disability community.